Administrative Core

The primary purpose of this COBRE Phase I application, “Center for Cellular Metabolism Research in Oklahoma
(CMRO),” is to establish a center of cellular metabolism research excellence at the Oklahoma Medical Research
Foundation (OMRF). Cellular metabolism is one of the fastest moving areas of biomedical research; however, it
has not been sufficiently integrated in Oklahoma. To address this unmet need, this COBRE will offer a critical
opportunity to unify OMRF’s metabolism-related resources and expertise to support five newly recruited junior
faculty and to foster increased cellular metabolism research and multidisciplinary scientific interactions overall in
Oklahoma. Our goal is to establish a recognized center of excellence in cellular metabolism research. In support
of these goals, the Administrative Core will provide centralized management and serve as the coordinating
resource through five Aims: 1) Provide central management and logistical support for the COBRE; 2) Provide
mentoring for the Project Leaders, and assist with their transition to stable independence; 3) Administer the Pilot
Project program; 4) Promote multidisciplinary approaches to the research of and interactions among the COBRE
investigators; and 5) Provide fiscal management, ensure compliance with regulatory issues, and promote data
sharing strategies. The Administrative Core will specifically ensure easy access to outstanding Core facilities
and a network of support that would be difficult to replicate elsewhere. This COBRE will have a long-lasting
impact on biomedical research in Oklahoma.